Determining how cell growth triggers cell division

PROJECT SUMMARY
The overarching goal of this project is to understand how cell growth triggers cell division in budding yeast and
identify general regulatory principles applicable to eukaryotic cells. Our work aims to understand how the most
basic aspect of cell morphology, cell size, is controlled. Solving this question has the potential to revolutionize
our understanding of how cell division is regulated in both natural developmental contexts and in disease.
In 2015, my laboratory reported a breakthrough discovery in understanding how growth triggers division in
budding yeast. While it was expected that growth would act to increase the activities of the cyclin-dependent
kinases (Cdk) known to promote cell division, this is not the case. Rather, we found that cell growth acts in the
opposite manner. Cell growth triggers division by diluting a protein that inhibits cell division, Whi5. This discovery
formed the basis of my first MIRA grant, which funded important progress in understanding G1/S cell cycle
control, cell size control, and its relationship to cellular senescence in both budding yeast and human cells.
This MIRA project builds on our prior discoveries by deepening our understanding of how budding yeast regulate
the size. More specifically, the project defines three new research directions: 1) Investigating the molecular
mechanism behind the size-independent transcription of WHI5, focusing on the role of forkhead transcription
factors. 2) Identifying Whi5-independent mechanisms that regulate cell size at the G1/S transition and defining
the role of the SBF transcription factor in this process. 3) Studying the role of Bck2 in the G1/S transition and its
interaction with the SBF transcription factor to understand its influence on cell size control. These directions aim
to uncover novel insights into the cellular machinery regulating cell size, which has broader implications for
eukaryotic cell biology and medical research.

Public health relevance
PROJECT NARRATIVE Cell size is a fundamental cellular property that is controlled by tying division to growth. We aim to determine the molecular mechanisms budding yeast cells use to control cell size to identify regulatory principles more generally applicable to eukaryotic cells.